Phosphate and Enamel Formation

PROJECT SUMMARY/ABSTRACT
Dental enamel is the most highly mineralized tissue in mammals and has no self-repair mechanism if
damaged. The major components to enamel are calcium (Ca2+), inorganic phosphate (PO43-; Pi) and hydroxide
(OH-). While several mammalian Pi cellular import channels are known, little is understood of Pi transcellular
and intracellular movements, and even less is known as to Pi cellular export as it relates to bone and teeth
mineralization. In enamel development two distinct formative stages are recognized; an extracellular protein
matrix-rich “secretory-stage”, immediately followed by the rapidly mineralizing “maturation-stage”. Preliminary
data indicate PiT1 is expressed in secretory-stage amelogenesis. Published data show that the Pi importer
NaPi2b, and the Pi exporter Xpr1 are both expressed during maturation-stage, suggesting that these proteins
contribute significantly to enamel mineralization. This leads to the hypothesis of this grant application that
“active transcellular and intracellular Pi movements dictate enamel mineralization processes”. If this can be
shown, a major paradigm shift in our basic understanding of enamel formation would transpire, including the
genetic controls involved in enamel biomineralization. To study the process of Pi movements in amelogenesis
we have access to five unique mouse models: K14-Cre, Odam-IRESCre, floxed Slc20a1/PiT1 (f PiT1), floxed
Slc34a2/NaPi2b (f NaPi2b) and floxed Xpr1 (f Xpr1) mice. In five Specific Aims we will: SA1) perform in situ
hybridization (ISH), RT-PCR, and immuno-fluorescence (IF) to study Cre-recombinase expression in Odam-
IRESCre heterozygous and homozygous mice; SA2) examine the contributions of PiT1 on secretory-stage
enamel mineralization; 3) examine the contributions of NaPi2b (Slc34a2) and Xpr1 (Slc53a1/Xpr1) in
maturation-stage amelogenesis by breeding Odam-IRESCre mice with respective floxed mutant mice strains;
SA4) use transmitted polarized light microscopy, reflected metallography, SEM, EDS, fracture toughness and
microhardness testing, performed on PN8 week fully mature mandibular incisor enamel, to study the
architecture/organization and mechanical properties of mutant teeth and in these same samples define the
atomic composition of the mineral composition; and SA5) ameloblast-like cell (ALC) culture will be examined to
study the dynamics of mineralization using siRNAs silencing of Slc20a1, Slc34a2 and Slc53a1/Xpr1 coupled
with Alizarin Red and von Kossa staining, and alkaline phosphatase activity, and also coupled with a thorough
total in silico RNA-seq analysis. In this study the clear focus is on the roles of PiT1, NaPi2b and Xpr1 in enamel
formation. With a recently developed enamel-specific Odam Cre-recombinase mouse line (Odam-IRESCre) we
are now in a unique position to study Pi-related activities in amelogenesis. The roles of Pi transporters in teeth
have had little prior attention, but for all dental researchers and practicing dentists, controls of Pi movements in
enamel Hap formation must be understood to better define amelogenesis.

Public health relevance
PROJECT NARRATIVE The primary atomic and molecular building blocks of enamel are calcium and inorganic phosphate (Pi), and a hydroxyl end group, that forms a hydroxyapatite (Hap) mineral under highly regulated extracellular pH conditions. The past 2 decades have offered significant insights as to how calcium and bicarbonate contribute to enamel formation, but today little information is known as to the molecular mechanisms involved in inorganic phosphate (Pi) movements from the circulation to the enamel space. Our work aims to explain the cellular roles of a Pi import channels (PiT1 and NaPi2b), and the only mammalian Pi export channel (Xpr1) in enamel formation.